EEG AND ERP EVALUATION OF CHILDREN WITH FETAL ALCOHOL SYNDROME

The aims are to use 2 electrophysiological measures, spontaneous EEG and evoked responses, to assess central nervous system functions in school-age children diagnosed with FAS, and to correlate these findings with other clinical data on the children, such as neurophysiological testing and MRI scans.